Discovering a novel therapy for RA patients

Rheumatoid arthritis (RA) is the most common autoimmune disease which affects 2.5 million people in
US, many of which are VA military personnel. One in four veterans has arthritis (25.6%), compared to one in
five civilians. RA is a chronic, disabling autoimmune disease in which the body attacks its own tissues. As RA
progresses, performing simple daily activities can become increasingly difficult for patients suffering from the
disease. There is no cure for RA and up to 50% of patients do not respond to anti-TNF therapies as circulating
Th17/IL-17 levels are highly elevated subsequent to TNF blockade. For this subset of RA patients, disruption of
a novel pathway that impairs the synergy between TNF and IL-17 cascades may provide an alternative
treatment. Effective therapies can benefit all active and retired military and VA members with RA, as well as
their families and friends who may suffer from RA. Findings that lead to new therapy will benefit the VA
personnel by reducing the cost for medical and surgical care; in addition to the secondary RA complications
including depression, cardiovascular disease and psychosocial stress. Consequently, effective RA therapy will
improve the pain & the life quality of the retired veterans.
We discovered that toll like receptor (TLR)5 is highly elevated in RA compared to normal macrophages,
and its expression closely correlates with RA disease activity score (DAS28). We also demonstrated that TLR5
natural ligands are present in RA synovial fluid. Ligation of TLR5 to its natural ligands, transforms RA
peripheral blood (PB) naïve cells into classical M1 macrophages (Mφs) which produce high levels of TNF, IL-6
and IL-1β. In addition, IL-6 and IL-1β produced from TLR5 driven M1 Mφs can differentiate the naïve T cells
into inflammatory RA Th17 cells that secrete IL-17. In mice, systemic and local injection of a TLR5 agonist
exacerbates joint swelling.
The objective of this proposal is to understand the cellular and molecular mechanisms of TLR5 function
and to evaluate whether TLR5 antibody (Ab) can be utilized as a promising strategy for RA therapy. We
hypothesize that ligation of joint TLR5 triggers differentiation of proinflammatory Mφs and T cells which can
ultimately expand the RA inflammatory process to the erosive phase. We further postulate that a novel TLR5
Ab generated by our lab may be an alternative treatment strategy for non-responders as it negates the
interaction of effector myeloid and lymphoid cells in RA.
To test our hypothesis, we will examine the contribution of RA Mϕ and T cell cross talk with endothelial
cells on bone neovascularization. Subsequently, to establish the preclinical stage efficacy, TLR5 Ab therapy
will be compared to the currently available treatments in RA cells and preclinical models. Successful
completion of this project will identify a novel mechanism that links the function of effector myeloid cells to
lymphoid cells as well as establishing a novel treatment strategy for RA patients that do not respond to the
current therapies.

Public health relevance
Rheumatoid arthritis (RA) is more prominent in women and has greater severity in Hispanics and Black populations. Recent wars have brought a new influx of veterans who are younger and are most prone to developing autoimmune connective tissue diseases, especially RA. Our clinic at the Jesse Brown VA sees around 700-900 RA patients annually. There is no cure for RA and up to 50% of the RA patients do not respond to current therapies. Therefore we aim to find a novel therapy that can slow or reverse RA progression. To resolve the critical barrier in RA treatment, we have identified a receptor which plays a central role in promoting joint inflammation and bone erosion. To investigate whether this identified receptor may be a novel target for RA therapy; a potent blocking antibody was engineered against this receptor. The goal of this proposal is to understand the identified receptor's mechanism of function and to evaluate whether the antibody engineered against this receptor can be utilized as a promising strategy for RA therapy.